Cell type-specific functions of microRNA in epilepsy

SUMMARY
At least 3.4 million people in the USA live with epilepsy. Despite a rapid increase in newly approved anti-seizure
drugs in the last decades, epilepsy is still intractable in about thirty percent of all cases. Alternative and
conceptually novel therapeutic strategies are therefore urgently needed. One group of promising novel treatment
targets are microRNAs, small noncoding RNAs that suppress the translation and induce the degradation of their
target mRNAs. MicroRNAs often target several components of the same pathway, making them powerful
regulators of biological processes. While this is an advantage when trying to treat complex diseases like epilepsy,
a disadvantage is the increased potential for side effects. This is a major obstacle reducing enthusiasm for the
use of microRNA as treatment targets in brain disorders. We will address this issue by using cell type-specific
strategies to test the hypothesis that microRNAs achieve specificity in controlling multiple aspects of brain
function by mediating their diverse roles through different cell types, brain circuits, and cell type-specific targets,
which could be leveraged to optimize treatment strategies. Most preclinical studies targeting microRNAs in
epilepsy have used cell type-unspecific antagomir (antisense oligonucleotide) approaches. These studies
revealed that several microRNAs shown to be crucial for seizure control in epilepsy also affect neuronal
morphology under healthy conditions, potentially reducing their value as treatment targets. The proposed
research will follow conceptually novel approaches to overcome this problem by using microRNA sponges.
MicroRNA sponges sequester and functionally inhibit microRNAs and can, in contrast to antagomirs, be
expressed under the control of cell type-specific promoters, thus inhibiting microRNAs only in select target cell
populations in the brain. Taking two epilepsy-relevant microRNAs as examples, we will first use microRNA
sponges under the control of neuron subtype- and astrocyte-specific promoters combined with adeno-associated
viral gene transfer to test if the effects of the microRNAs on seizure susceptibility and neuronal morphology can
be separated by cell types in the brain (aim 1). To provide insight into the underlying mechanisms and the cell
type-specific mRNA targets of the microRNAs, we will combine the microRNA sponges with transgenic mice that
Cre-dependently express epitope-tagged RNA-induced silencing complex (RISC) allowing for the specific
isolation of RISC-associated mRNA from only those cells that express the viral sponge (aim 2). Comparing the
RISC-associated transcriptome from cells transduced with scrambled versus microRNA-specific sponges we will
experimentally identify cell type-specific microRNA targets. Our strategy will take advantage of the multiplex
function of microRNAs regulating hundreds of mRNAs while maximizing specificity by manipulating microRNAs
in the cell types that are the most relevant for the targeted phenotype. This research may be the first step towards
the development of safe and effective microRNA-targeted therapies in epilepsy.

Public health relevance
NARRATIVE Brain disorders like epilepsy are difficult to treat because of the complexity of the underlying pathogenesis. MicroRNAs, which are potent regulators of multiple molecular pathways in a cell, have emerged has potential treatment targets for complex disorders like epilepsy. The proposed research will advance our understanding of the cell type- and circuit-dependent functions of microRNAs in epilepsy and the healthy brain, which ultimately can lead to the development of optimized treatment strategies for epilepsy.